Translation of overprinted non-canonical open reading frames from alternative transcript variants

This project describes a class of recently discovered human genes: internal open reading frames (iORFs) that
overlap annotated protein coding sequences in alternative reading frames. Because iORFs are translated in a
different reading frame, their amino acid sequences are different from the annotated protein that they overlap,
meaning that overlapping genes encode two entirely different protein products. Overlapping genes are well-
characterized in viral genomes, but were thought to be essentially absent from the human genome. While
evidence is growing that the microproteins encoded in iORFs can play important roles in human cells, it is
currently unclear how many functional human iORFs exist and how they are expressed. We provide
preliminary data demonstrating that, in potentially hundreds of cases, alternative transcript variants can recode
a human gene from expressing the annotated, canonical protein to the iORF-encoded microprotein. In Aim 1,
we will apply long-read sequencing technologies to identify and validate the existence of iORF-encoding
alternative transcripts in high throughput, thus establishing how broadly iORF recoding occurs in human cells.
In Aim 2, we will provide molecular and cellular evidence that iORFs are functional, and determine whether
their cellular roles are related to those of the canonical proteins that they overlap despite their differing amino
acid sequences. In Aim 3, we will characterize the molecular mechanism and regulation of an anti-apoptotic
iORF that overlaps a pro-apoptotic death effector domain-containing protein. Taken together, the successful
completion of these aims will demonstrate that overlapping human genes are plentiful and functional, and
provide mechanistic insight into a specific overlapping gene as a paradigmatic example of the molecular
rationale for overlapping gene organization in human. More broadly, our study will provide an entirely new
understanding of the roles of alternative transcript variants generated via alternative pre-mRNA splicing and
use of alternative transcriptional start site: instead of simply generated isoforms of known proteins, these
processes can generate novel transcripts that, in losing the ability to encode the annotated protein coding
sequence, can be reprogrammed to express frameshifted iORFs encoding currently unannotated microproteins
with distinct sequences and functions. We thus expect to reveal new levels of complexity in the human
transcriptome and proteome.

Public health relevance
New technologies in genomics and proteomics have revealed thousands of previously undiscovered, yet functional, microproteins encoded in the human genome. In this study, we will demonstrate that an understudied, plentiful class of microproteins that overlap known human protein coding sequences has important roles in human cells, and that their expression relies on novel mRNA mechanisms that reprogram the coding potential of human genes. This project will therefore reveal entirely new dimensions of complexity and regulation of human protein-coding genes, with important implications for human biology and disease.